Molecular Biophysics Training Grant at UC San Diego

ABSTRACT. The goal of the Molecular Biophysics Training Grant (MBTG) at the University of California San
Diego is to provide a rigorous and strongly interdisciplinary training program for graduate students, with the aim
of training the next generation of scientific leaders striving to solve important biological problems using Molecular
Biophysics approaches. To accomplish this goal, trainees with strong quantitative backgrounds and a
demonstrated aptitude, commitment, and passion for research are selected at the end of their first year from a
diverse group of applicants from 32 well-funded training faculty labs. The MBTG faculty are highly
interdisciplinary and many have cross-campus appointments in several departments. Trainees come mostly from
two graduate programs, Chem/Biochem and Biomedical Sciences but a few come from Physics, Biology and
Bioengineering. During their first year, all students engage in research rotations and choose a research lab. At
UCSD, students are free to rotate with any faculty across campus and to choose any faculty for their thesis
advisor. First year students receive training from their respective graduate programs in critical reading of
literature, exposure to important unsolved biological problems, ethics and graduate school survival skills. MBTG
Trainees are appointed and choose their thesis committee at the end of their first year. All MBTG trainees take
two rigorous core courses in Molecular Biophysics and will have an intensive week-long Statistics workshop.
During their second year, they write and defend their thesis research proposal. Required trainee activities include
a full-length seminar presentation of their research at the monthly student seminar, monthly discussions of rigor
and reproducibility, a monthly journal club, a yearly retreat, career workshops and outside mentors. Trainees
may apply to be reappointed for a maximum of two years of support. All trainees present their research every
year at the annual retreat, with alumni trainees giving lightning talks each year until graduation. Throughout their
graduate training, trainees take advantage of career development opportunities and mentorship, including yearly
IDPs and group and individual engagement with outside mentors. The program emphasizes the development of
creative independent thinking, strong quantitative skills with a focus on rigor and reproducibility, scientific
communication, and mentoring. The MBTG provides the critical interdisciplinary “home” at UCSD for students
and faculty interested in Molecular Biophysics. The high quality of student publications, postdoctoral fellowships,
faculty positions, and industry positions obtained by our trainees are strong evidence of successful training
outcomes. Given the depth, quality, and diversity of our student pool and our demonstrated training outcomes, we
request 12 students be supported each year.

Public health relevance
The future of biomedical research in the U.S. will depend on the rigorous training of PhD scientists who can think critically and independently, and who use cutting edge Molecular Biophysical approaches to solve important biomedical problems. The Molecular Biophysics Training Program at the University of California, San Diego fosters the development of dedicated Molecular Biophysics researchers who can apply rigorous research approaches across disciplinary boundaries, choose research problems with important human health implications, and communicate their results effectively. The Program serves as the campus “home” for Molecular Biophysics, and provides rigorous training, high-quality individual mentorship, and career guidance for graduate students from different graduate programs pursuing research projects in the area of Molecular Biophysics.